Multimodal behavioral analysis of oromanual food-handling in freely moving animals

PROJECT SUMMARY
Oromanual food-handling – in which the hands and forelimbs work in a coordinated manner with the mouth and
jaw to manipulate and consume a food item – is a fundamental behavior common to many rodent species as
well as primates. Despite its ethological significance, oromanual food-handling has received remarkably little
experimental attention, reflecting the technical challenges of recording at sufficient spatiotemporal resolution a
behavior involving small, fast, and often visually occluded movements. We recently initiated efforts to overcome
these challenges, developing paradigms for analyzing food-handling in mice using high-speed close-up video
methods coupled with AI-based kinematic tracking. Here we propose to build on these advances through a set
of planning activities leading to a powerful new approach for in-depth investigation of this behavior. The overall
objective is to develop new experimental and analytical paradigms for recording food-handling behavior with
high spatiotemporal resolution in freely moving animals, with a focus on understanding how elemental sub-
movements are assembled into distinct goal-directed actions coordinated across multiple body parts. The
technical approach includes design of a videographic recording arena incorporating a robotic camera positioning
system. Electromyography from jaw-controller and forelimb muscles in freely moving mice will enable
characterization of the elements of dexterous coordination involved in manipulating the food with both hands and
jaw. Intranasal detection of breathing will enable characterization of sniff-related movements during food-
handling, posited to represent an additional aspect of the behavior engaging the olfactory and respiratory
systems. Exploratory studies will extend the approach in comparative, ecological, and developmental directions.
The analytical approach will conceptualize the behavior in terms of the multiple components of the motor plant
and behavioral modes and actions, including detailed ethogramming and incorporating machine learning-based
tracking, modeling, and related computational methods. The anticipated results will constitute an innovative
paradigm for quantitative analysis of food-handling, setting the stage for a future investigation of the neural
mechanisms of this natural form of goal-directed dexterous behavior. Results from this research program
furthermore have high potential to identify common principles of natural, complex, motor behavior in mammals
in general.

Public health relevance
NARRATIVE The proposed research on natural food-handling behavior in freely moving mice is relevant to public health, both for advancing fundamental neuroscience knowledge about mammalian behavior and brain function and because a wide spectrum of common disorders can impair these behaviors in humans. The proposed research is thus relevant to those aspects of the NIH mission aimed at improving health through understanding pathophysiological mechanisms in disorders causing disability.